CONCEPT TO CLINIC: COMMERCIALIZING INNOVATION (C3I) PROGRAM TRAINING

Concept to Clinic: Commercializing Innovation (C3i) Program is designed to provide medical device innovators with the specialized business frameworks and essential tools for successful translation of biomedical technologies from the lab (concept) to the market (clinic). Through this program, the NIH fosters the development and commercialization of early-stage biomedical technologies by engaging investigators who are interested in better understanding the value of their innovation in addressing an unmet market need. The curriculum and customized mentoring provided by the C3i Program are intended to guide investigators as they assess the commercial viability and potential business opportunity for their innovation. https://www.nibib.nih.gov/research-program/c3i-program
This contract is to support services needed to create entrepreneurial training materials, coordinate course learning activities, recruit experienced business advisors and mentors, and perform an outcomes assessment.